Early life dysbiosis, and skin barrier function

Abstract
The prevalence of atopic diseases such as atopic dermatitis (AD) and asthma are increasing at high rates that
can't be explained by purely genetic etiology, indicating the roles of environmental exposures in increasing
disease risk. Environmental exposures that alter the risk of allergic diseases (farm exposure, C-section, breast
feeding, antibiotic exposure) also influence microbial colonization. Altered microbial composition (aka dysbiosis)
at mucosal surfaces, specifically within the perinatal period (<1 year of life) has been linked to increased risk for
developing several atopic diseases. Interestingly, atopic diseases are also associated with epithelial barrier
dysfunction. Our preliminary data suggest that perinatal dysbiosis is associated with 1) increase in allergen-
induced pulmonary responses; 2) a period of increased skin permeability (barrier dysfunction) extending even
after resolution of immediate dysbiosis; 3) significant alterations in gene expression in the skin of dysbiotic
animals, including dampened TNFα signaling, and predominantly Th2 biased transcriptomic profiles.
Interestingly, an isolate of gram negative commensal Roseomonas mucosa identified from healthy volunteers
(RMhv) was associated with increased skin barrier function and clinical benefits demonstrated by mouse studies
and clinical trials. RMhv-induced improvement in skin barrier function were linked to elevated TNF-related
epithelial repair mechanism. Therefore, we hypothesize that by impairing skin barrier function, perinatal dysbiosis
can exacerbate sensitivity to the development of skin-associated allergic diseases, and that treatment with a
clinically relevant Roseomonas mucosa bacterial isolate is sufficient to protect mice from perinatal dysbiosis-
associated defects in skin barrier function. This hypothesis will be tested in two Aims: (1) To determine if perinatal
dysbiosis alters susceptibility to the development of skin-associated allergic diseases; (2) To determine if a
clinically relevant Roseomonas mucosa isolate identified from healthy volunteers can protect mice against
perinatal dysbiosis associated skin barrier dysfunction and house dust mite allergen -induced allergic diseases.
Collectively, these studies will elucidate the mechanisms by which perinatal dysbiosis influences skin barrier
function and associated allergic diseases.

Public health relevance
Narrative Early life dysbiosis induce skin barrier dysfunction and changes skin transcriptomic profile which might increase the risk for skin-associated allergic diseases. Topical treatment with a clinically beneficial isolate of commensal bacterium Roseomonas mucosa could protect from barrier dysfunction induced by perinatal dysbiosis.